PLATELET MEMBRANE PROTEINS IN AGGREGATION

This proposal is a request for funding of years 13 through 17 of an ongoing project designed to study membrane proteins involved in platelet aggregation. Platelet aggregation is a fundamental reaction in hemostasis and thrombosis and appears to be mediated by the glycoprotein (GP) IIb-IIIa complex in platelet membranes. Previous work from this laboratory has i) purified this glycoprotein complex and studied its physical, chemical and morphological properties; ii) identified and characterized some of the biological properties of GP IIb-IIIa such as binding of ligands and interaction with actin filaments; and iii) demonstrated that GP IIb-IIIa-like glycoproteins exist in endothelial cells and smooth muscle cells. The present study is designed to extend this later finding by characterizing the structural and functional properties of the GP IIb-IIIa-like glycoproteins of endothelial cell and smooth muscle cell membranes and by testing the hypothesis that these properties are related to those of GP IIb-IIIa in platelets. Monoclonal antibodies to the GP IIb-IIIa-like complex in endothelial cells and smooth muscle cells will be raised and used to purify the glycoproteins from these two cells and to test for potential functions of these glycoproteins. Biochemical and receptor-binding properties of the isolated glycoproteins will be determined and compared to platelet GP IIb-IIIa. Studies are outlined to deduce the primary amino acid sequences of GP IIb- and Gp IIIa-like glycoproteins using recombinant cDNA libraries prepared from endothelial cells. The primary sequences of the glycoproteins in nucleated cells will be compared to partial sequences determined for platelet glycoproteins to determine whether platelet and endothelial cell GP IIb-IIIa are products of the same gene or are members of a family of closely related genes. It is anticipated that this study will establish new information on the structure and function of the membrane glycoproteins in the cells of the blood vessel wall and will initiate a molecular biology approach to the study of regulation and organization of the genome(s) of the GP IIb-IIIa complex.